Polarized Protein Trafficking and Angiogenesis

SUMMARY
Blood vessels carry oxygen and nutrients and are vital to organismic viability and continued homeostasis.
Angiogenesis, or the formation of new blood vessels from pre-existing ones, is the predominant developmental
process by which blood vessel network density is regulated. During angiogenic development, endothelial cells
create a hollow cavity called a lumen, providing a continuous conduit for blood to reach distant tissues. The
mechanisms underpinning the morphodynamic changes in endothelial architecture and signaling leading to
vascular lumen formation, or tubulogenesis, are incompletely understood. In this proposal we will investigate a
protein called synaptotagmin-like protein 2 (sytl2) that we believe is responsible for deﬁning the luminal surface
by directing protein transport to the apical membrane during blood vessel development. Our preliminary data
suggests that sytl2 deﬁnes the apical membrane and tethers Rab GTPase proteins for delivery of vesicular
cargo, such as podocalyxin. In aim 1, we will characterize the role of sytl2a during vascular lumen formation in
developing zebraﬁsh embryos using a combination of live-imaging and CRISPR-based mutant generation. In
aim 2, we will comprehensively demonstrate that sylt2 works in combination with the GTPase Rab35 to deliver
podocalyxin to the apical plasma membrane during lumenogenesis in vitro. In aim 3, we will further
characterized how sytl2a interacts with Rab35 to deliver Podocalyxin using generation of new zebraﬁsh
reporter lines and compound mutants in vivo. How blood vessel lumen formation is regulated is still a major
question in the ﬁeld, this proposal will provide novel insight into critical mechanisms orchestrating this process.

Public health relevance
NARRATIVE Blood vessels carry oxygen and nutrients and are vital to organismic viability and continued homeostasis. During angiogenic development, endothelial cells create a hollow cavity called a lumen, providing a continuous conduit for blood to ﬂow. This proposal will help determine the molecular and cellular mechanisms that contribute to the creation of a lumen during embryonic blood vessel development.